FUNCTIONAL MRI IN HUMANS AT 7 TESLA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Currently, the vast majority of magnetic resonance imaging and functional imaging studies are conducted at relatively low magnetic fields of 1.5 or 3.0 Tesla. However, theoretical considerations as well as experimental evidence have suggested that there is a fundamental dependence of image signal to noise ratios, functional imaging contrast and spatial specificity on the magnetic field strength. The general aim of this proposal is development of fMRI and MRI techniques for whole brain acquisitions at high magnetic fields (7 T &9.4 T). In achieving this aim, fMRI/MRI studies will be conducted at the ultra-high magnetic field of 9.4 Tesla for the first time in humans.